PROCAINE AND FUNCTIONAL IMAGING OF LIMBIC STRUCTURE

The purpose of this study is to demonstrate activation of limbic structures following procaine injection, using PET technology. In these studies, fMRI will be obtained on a conventional 1.5T scanner. PET studies will use 150 on FDG as probes to relate changes in regional blood flow to regional glucose utilization.